Oral Health Influences Among Emerging Adult Women of Central and South American ancestry

Modified Project Summary/Abstract Section

Oral diseases are among the most common chronic conditions of humankind; their origins can often be traced
to economic and behavioral circumstances much earlier in life. Frequently overlooked are key life transitions
when behaviors and circumstances are especially fluid and potentially malleable with appropriately tailored
interventions. Emerging adulthood (the transitional period from adolescence to adulthood) is one such life
stage that has garnered limited attention in oral health research. Emerging adulthood is a particularly sensitive
period marked by changes in economic stressors, health risk factors, and potential protective opportunities as
young people enter new circumstances. This proposed project combines detailed measures of economic,
social, and behavioral factors with high-quality assessments of oral and systemic health in a diverse,
prospective emerging adult cohort. We will examine potential interactions by ancestry and sex and the specific
behavioral pathways connecting economic factors to disease risk, potentially revealing health promotion
opportunities during this formative developmental period. Indeed, such insight informs a long-term objective to
test how acquired access to economic opportunity afforded by higher education impacts the trajectory of oral
diseases, including among those from different backgrounds.
This proposal leverages the NHLBI-supported Economic and Educational Contributions to Emerging Adults'
Cardiometabolic Health (“3E”) cohort study of first-year college students from two public universities. This
proposal augments rich prospective economic and behavioral data with oral health-specific risk factors and
self-reported and objective measures oral health. Specifically, this project will: Aim 1. Examine the influences
of early adulthood economic stressors on oral health over time, including as potentially modified by ancestry
and sex. Aim 2. Examine the contributions of education-related opportunities (e.g., academic engagement
programming, basic needs supports, social capital) as protective factors against adverse oral health outcomes
(e.g., service non-utilization, gingival inflammation). Aim 3. Assess the mechanistic role of health-related
behaviors in linking economic stressors and education-related opportunities to oral health outcomes.
Emerging adulthood, a transition period in health behaviors and economic opportunity, is a potential pivot point
in the development of chronic diseases. Understanding influences of oral diseases near their emergence will
inform more effective oral disease prevention efforts.

Public health relevance
Modified Public Health Relevance Section While oral diseases are extremely common and can meaningfully reduce quality of life, relatively few studies have examined the causes of oral diseases during young adulthood, a time when many individuals experience a transition in their economic and social circumstances that can lead to changes in their behaviors and their risk of disease. This study will collect detailed information about economic status and health behaviors, as well as general health and oral health, among college students from many different backgrounds. Such information will increase our understanding of the early stages of long-term oral diseases, including diseases that can lead to future problems like tooth loss, in order to help develop programs and policies that can eventually improve oral health for everyone.